Cellular and Molecular Mechanisms of Germline Regeneration

PROJECT SUMMARY
Humans and well-established research organisms lack the ability to regenerate their reproductive cells (germ
cells) and reproductive organs. Research findings from these organisms established the current view that germ
cells are a distinct lineage separated from the soma; therefore, the loss of germ cells renders an organism infertile
because new germ cells cannot be derived from the soma. Contradicting this widely accepted view is the fact
that many organisms (e.g. hydra, flatworms, segmented worms, and sea stars) can readily regenerate germ
cells. However, the cellular source of regenerated germ cells in these organisms is very poorly understood. The
goal of my laboratory is to close this knowledge gap and define the cellular origins and molecular
mechanisms of germ cell regeneration. Addressing this is not feasible using established research organisms
like mice, fruit flies, and nematodes, because they do not regenerate germ cells. Furthermore, many of the
organisms that can regenerate germ cells are not conducive to studying the mechanisms of this process because
they lack transgenic tools, or their anatomies present technical challenges such as large and opaque bodies, or
inaccessibility of reproductive organs. These limitations prevent the use of live imaging – a key tool to trace the
lineages of germ cells and their source cells. We use a segmented worm, Platynereis dumerilii, for studying germ
cell regeneration. Platynereis is well-suited for this study because germ cell regeneration can be induced and is
achieved quickly; transcriptome databases, a draft genome, and transgenic tools (critical for genetic lineage
tracing) are available; and a small and transparent body makes it excellent for live imaging. Therefore,
Platynereis is a research organism that presents a rare opportunity to combine the modern techniques
required to study germ cell regeneration (live-imaging, genetic lineage tracing, transcriptomics) in the
relevant post-embryonic life stages (i.e. juveniles, adults) which are typically challenging to image live.
We postulate three possible models for the cellular sources for the regenerated germ cells: 1) pluri/multipotent
stem cells regenerate both somatic and germ cells; 2) a lineage-restricted cell population is dedicated to
regenerating only the germ cells; or 3) somatic cells transdifferentiate into germ cells by reprogramming. Our
experimental approach will be to: a) Test between the three cellular models of germ cell regeneration via genetic
cell lineage tracing and live imaging. This will allow us to identify the exact cell lineages that give rise to germ
cells during development and regeneration. b) Identify the molecular changes taking place during reprogramming
source cells into germ cells by single cell RNA sequencing. This will allow us to obtain transcriptome trajectories
over the course of regeneration and identify cell type-specific markers in the source cells, the intermediate states,
and the new germ cells. These markers will be tested for function in future studies. The project will significantly
contribute to our fundamental understanding of germ cell biology and the soma-germ cell distinction.

Public health relevance
PROJECT NARRATIVE If humans lose their reproductive cells (i.e. eggs and sperm) they become infertile, in contrast, some animals regenerate their reproductive cells and reproductive organs. This project’s goal is to uncover the mechanisms of reproductive cell and tissue regeneration by identifying the cell types and genes involved in this process. Through its focus on reproductive cell regeneration, stem cell activity, and cell reprogramming, our project will contribute to our fundamental knowledge of reproductive and stem cell biology and will inform regenerative medicine approaches.